Molecular Mechanisms of Myoblast Fusion

PROJECT SUMMARY
Skeletal muscle is a unique organ that is composed of multinucleate muscle fibers, each of which is the
product of fusion of hundreds or even thousands of myoblasts. Myoblast fusion is not only important for
skeletal muscle development, but also critical for satellite cell-based muscle regeneration. Despite a large body
of studies over several decades, the mechanisms underlying myoblast fusion in humans remain poorly
understood. Studies in the fruit fly Drosophila have revealed unprecedented insights into the molecular and
cellular mechanisms of myoblast fusion. The striking evolutionary conservation between fly and mammalian
myogenesis makes Drosophila a particularly relevant system to study myoblast fusion in vivo. Recent studies
from our lab have uncovered a novel cellular mechanism underlying myoblast fusion. We show that myoblast
fusion is mediated by F-actin-enriched podosome-like structure (PLS), which invades the apposing fusion
partner with multiple protrusive fingers leading to fusion pore formation. Despite the discovery of the PLS, how
the fusion signal is transduced from the cell adhesion molecule to the actin cytoskeleton remains unclear. In
this proposal, we will address two long-standing questions in myoblast fusion – how the myoblast fusion
program is initiated in muscle cells and how the fusion signal is transduced from the cell adhesion molecules to
the actin cytoskeleton. We will characterize the surprising inter-organ ecdysone signaling in the transcriptional
activation of muscle-specific genes, investigate the mechanism by which phase separation organizes the
fusion machinery, and elucidate the function of an Arf GEF in regulating actin polymerization at the fusogenic
synapse. Our mechanistic studies will lead to significant insights into skeletal muscle development and
regeneration.

Public health relevance
PROJECT NARRATIVE Myoblast fusion is an essential step during skeletal muscle development and muscle stem cell-based regeneration. Understanding the mechanisms of myoblast fusion will lead to significant insights into human muscle biology in health and disease, and ultimately provide a basis for developing more efficient therapeutics against the life debilitating muscle degenerative diseases.